Project 1: Endothelial cell programs for coronary artery disease

PROJECT SUMMARY: Project 1
Coronary artery disease (CAD) remains the leading cause of death throughout the world despite therapies
targeting leading risk factors, calling for the rapid development of new treatments. One approach is to use human
genetic association studies to identify medically targetable pathways. However, finding disease-causing genes
has been a slow endeavor because it requires testing one gene at a time and there are over 300 CAD loci. Our
lab recently demonstrated that a new technology called Perturb-seq can dramatically increase this discovery
pipeline because it can functionally characterize all 300 CAD loci in one experiment by identifying convergence
of risk pathways. When we performed this assay in primary human endothelial cells (ECs), we discovered that
41 CAD risk loci converge onto a small number of common pathways that could promote disease risk. The major
disease-associated pathway we identified contained several genes previously associated with Cerebral
Cavernous Malformations (CCM), a rare neurovascular disease. Common variants in the CCM-signaling
pathway were consistently protective for CAD risk, despite established pathogenic roles for these genes for
neurovascular disease. We showed that two CAD-associated genes—CCM2 and TLNRD1—interact in the CCM
complex and regulate many other CAD risk genes and the endothelial shear stress response. Given this success,
Project 1 will use our recently developed in vivo Perturb-seq capabilities to rapidly map out disease mechanisms
of the CCM pathway in the whole organism and identify CAD gene programs active in diseased arteries.
Specifically, we need to understand why mutations in the CCM-signaling pathway are pathogenic for
cerebrovascular disease, but protective for CAD. Our experiments will address the central hypothesis that the
CCM signaling pathway is a major determinant of CAD risk, with context-dependent effects on ECs that depend
on the stage of atherosclerosis, dosage/degree of gene inhibition, and EC subtypes from vascular beds in
different organs. Applying new innovations for in vivo Perturb-seq developed by our Scientific Cores, the Aims
of Project 1 are to 1) determine context-dependent effects of 250 genes in 3 stages of murine atherosclerosis;
2) characterize the effects of EC-specific TLNRD1 knockout on atherosclerosis, vascular development,
arteriogenesis, and angiogenesis; and 3) identify the organotypic effects of CCM2/TLNRD1 knockdown in brain,
lung, and aortic ECs. Our study will be highly synergistic with the other Projects in the Program, enabling
comparison of causal CAD programs between ECs and smooth muscle cells (with Project 2), and comparisons
of the functions of EC genes and programs between two distinct diseases (CAD vs. pulmonary arterial
hypertension with Project 3). Through integration across all 3 Projects, we will address the central goal of the
Program to identify cell-type specific effects of causal genes in multiple vascular cell types and prioritize the
pathways with the greatest translational relevance for therapy and prevention.